Harnessing Tumor and Circulating-Free DNA Methylation for Prognosis and Treatment Stratification in Adenoid Cystic Carcinoma

Abstract
Adenoid Cystic Carcinoma (ACC) is a common salivary gland cancer for which there is no standard systemic
therapy. ACC has a heterogeneous behavior; while most patients have an indolent disease course,
approximately 30% have a very aggressive disease. There are currently no standard markers to prognosticate
or for selecting treatment. Epigenetic changes are tightly linked to tumorigenesis and cancer progression and
numerous studies imply that DNA methylation may serve as a valuable biomarker to identify molecular disease
subtypes. However, studies evaluating whole ACC methylome and the evolutionary trajectories of methylation
during the initiation and progression of ACC are lacking. We identified methylation intertumor heterogeneity in
ACC and differentially methylated gene regions according to ACC transcriptomic subtype. Additionally, we also
identified circulating tumor DNA in blood of ACC patients and their levels correlated with disease recurrence,
response to therapy or disease progression, suggesting clinical utility of ctDNA dynamics. Our central hypothesis
is that the DNA methylation signature in ACC can identify prognostically distinct and therapeutic relevant
molecular subtypes and circulating methylation markers may be used as a non-invasive tool for real-time
subtyping stratification and treatment monitoring. In Aim 1 we will examine the DNA methylation and
transcriptomic profiles in 200 clinically annotated ACC tumors with long term follow-up and assess the value of
DNA methylation in refining transcriptomic based ACC subtyping. In Aim 2 we will profile the
methylation/transcriptome of paired primary and metastatic tumors to identify metastatic specific changes and
develop a metastatic propensity score to predict metastatic site. In Aim 3 we will profile DNA methylation in
circulating free DNA from matched tumor and blood samples, collected as part of a prospective study already
initiated, and develop a blood-based methylation score for ACC subtyping. Additionally, we will validate the
significance of our blood-based methylation score in detecting ACC subtype evolution and to predict treatment
response using blood samples collected as part of our clinical trials. Our research will be the first to investigate
ACC DNA methylation markers to identify aggressive ACC at initial diagnosis and throughout tumor progression.
Accurate diagnosis through a simple blood test will allow clinicians to detect the evolution of the disease in real-
time and guide treatment selection.

Public health relevance
Project Narrative Adenoid Cystic Carcinoma (ACC) is a salivary gland head and neck cancer with high recurrence rate and despite the significant biological and clinical variability, all patients are treated the same. There is no standard of care systemic therapies for patients with this orphan disease. This proposal is pertinent to public health because it will identify clinically significant, reliable, prognostic, and predictive DNA methylation biomarkers, which will address a clinical gap-specifically, the lack of biomarkers for prognostication, and to guide patient stratification for treatment selection in ACC. Thus, our proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burdens of human illness.